Evaluation of the Caring Letters Suicide Prevention Intervention after Removal of an Electronic Health Record Flag for Suicide Risk: An Effectiveness-Implementation Hybrid Type 2 Trial

ABSTRACT
In the electronic health record (EHR), the Veterans Health Administration (VHA) uses patient record flags
during periods of high acute risk for suicide (e.g., following a suicide attempt) to alert clinicians and improve
suicide prevention services. Unfortunately, recent analyses revealed that after these high-risk flags (HRFs) are
discontinued based on clinical judgement, suicide rates remain high in the year that follows. This creates a
suicide prevention challenge. To address this need, VHA facilities were required in 2020 to start implementing
the Caring Letters suicide prevention intervention for this population. In the Caring Letters intervention, a series
of messages are sent to individuals to communicate that they are not forgotten, and that people care about
them and are concerned for their well-being. The messages also serve as a reminder that help is available.
Multiple randomized clinical trials support the efficacy of Caring Letters for reducing suicide behaviors in acute
care settings. The Joint Commission recently promoted Caring Letters, and the intervention is included in the
VA/DoD suicide prevention Clinical Practice Guideline for acute care settings. Unfortunately, the mandate to
use this intervention with Veterans with a discontinued HRF (VD-HRF) has faced many challenges. Less than
half the facilities across the nation have implemented the program. For facilities that have implemented the
program, several concerning fidelity problems have been identified, indicating that thousands of Veterans in
those catchment areas are not receiving the intervention as intended. Therefore, we propose a partnered
program evaluation between the VHA Suicide Prevention Program (SPP), and the proposed evaluation team to
examine a new version of the intervention for this unique population. Specifically, the evaluation will
randomize all VA facilities to either: (1) Centralized Caring Letters where all the work of administering Caring
Letters is centralized with a single, national team (promoting high fidelity and compliance with the requirement),
or (2) De-Centralized Caring Letters in which VA facilities continue their local procedures as usual during a 6-
month delay before starting Centralized Caring Letters. We will conduct an effectiveness-implementation
Hybrid Type 2 trial. As a Hybrid Type 2 trial, the study has dual primary goals. The first is to test the
effectiveness of a Caring Letter campaign for VD-HRFs, a relatively new population for the intervention. The
second goal is to evaluate the impact of adding an implementation strategy – centralizing the work of Caring
Letters – to the existing strategy of mandating change. The evaluation will test two aims. In Aim 1, we will
evaluate the effects of Caring Letters on clinical outcomes and VA clinical utilization rates. An exploratory aim
will also examine rates of suicide attempts, all-cause mortality, and suicide for Veterans who receive
Centralized Caring Letters compared to a historical cohort who received no Caring Letters. In Aim 2, we will
evaluate the impact of adding the implementation strategy of centralizing the work of the intervention to the
existing implementation strategy of mandating change. Using qualitative interviews, we will evaluate
leadership, staff, and provider perspectives on the implementation and sustainability of Centralized Caring
Letters. This will be one of the largest evaluations of a Caring Letters intervention ever conducted, and it will
provide direct and actionable data to leadership to evaluate the impacts of this major prevention program.

Public health relevance
PROJECT NARRATIVE A 2020 VA policy required VA facilities to start sending Caring Letters to Veterans after a high-risk for suicide flag was inactivated in the Veteran’s electronic health record. Unfortunately, compliance with the mandate and fidelity to the intervention is poor. In response, VA Central Office’s Suicide Prevention Program (SPP) is planning to implement a centralized, national approach to Caring Letters for this population. This evaluation proposes to partner with the SPP to develop the intervention and evaluate both the clinical effectiveness and the implementation of the program. The evaluation will examine two implementation strategies (Centralized Caring Letters or Decentralized Caring Letters as usual) using a standard evaluation analytic framework. VA data and data obtained from Veteran, staff, and leadership key informant interviews will be used in the evaluation.